Environmental Health Research Institute for Nurse and Clinician Scientists (EHRI-NCS)

ABSTRACT
Rigorous environmental health science methods are underutilized in research relevant to nursing practice. This
underutilization is a unique and important gap as the nursing discipline represents the largest proportion of all
health care providers. The Environmental Health Research Institute for Nurse and Clinician Scientists (EHRI-
NCS) is designed to build the nursing discipline-wide capacity and rigor for translational and clinical research
methods in environmental health. The goal of this program is to enhance the discipline-wide capacity of nurse
scientists and their interdisciplinary clinician scientist collaborators for advanced research methods in
environmental health through a flipped classroom, train-the-trainer and mentorship program. This program is
timely to build upon the American Academy of Nursing’s 2019 declaration of environmental health as one of
the discipline’s five topical priorities. The flipped classroom model will be utilized as the best-practice pedagogy
to achieve higher order learning objectives with pre-recorded, online didactic lectures provided for participant
preparation, followed by a synchronous 5-day training and post-course mentorship follow-up. The objectives
are for the participant to 1) Design clinical research studies and research education with advanced
environmental health methodologies, 2) Mentor other peer, student, and early career nurse scientists in
environmental health methodologies, 3) Examine broader theoretical, philosophical, ethical, and legal contexts
related to environmental health exposure science with implications for clinical policy, practice, education, and
research, 4) Analyze strategies used for clinical environmental health interventions, 5) Describe trends in
environmental health molecular approaches of symptom science, 6) Acquire new analytic skills applied to
environmental health data, and 7) Compare and contrast the strengths, weaknesses, and applications of
environmental exposure science measurements and methods in clinical research. We will recruit participants
who have already achieved their terminal doctoral degree and those currently enrolled in a graduate nursing
program who educate, train, and mentor registered nurses in research trajectories. We will include specialized
recruitment and support structured for participants from under-represented minority groups. Course topics will
include 1) Theoretical conceptualization, 2) Intervention Study Designs, 3) Participatory Action Designs, 4)
Physiologic Measurement with Spirometry, 5) Biomarker Measurement, 6) Personal and Area Exposure
Measurement, 7) Informatics and Analytics, and 8) Health Disparities and Vulnerable Populations. Aligned with
the NIH/NIEHS 2018-2023 strategic goal to “Enhance environmental health science through stewardship and
support,” the impact of this successful program will include developing a discipline-wide, highly qualified
research workforce dedicated to solving environmental health problems relevant to nursing practice.

Public health relevance
NARRATIVE We seek to build the nursing discipline-wide capacity and rigor for translational and clinical research methods in environmental health through the Environmental Health Research Institute for Nurse and Clinician Scientists (EHRI-NCS). The goal of this program is to enhance the discipline-wide capacity of nurse scientists and their interdisciplinary clinician scientist collaborators for advanced research methods in environmental health through a flipped classroom, train-the-trainer and mentorship program.